Animal Feed Regulatory Program Standards (AFRPS) Maintenance and the Enhancement of Current Good Manufacturing Practices (cGMP) and Preventive Controls for Animal Food Regulatory (PCAF) Activities

Project Summary/Abstract
Animal Feed Regulatory Program Standards (AFRPS) Maintenance
and the Enhancement of Current Good Manufacturing Practices
(cGMP) and Preventive Controls for Animal Food (PCAF) Regulatory
Activities
FOA: PAR-20-13 Development and Maintenance of the Animal Feed Regulatory Program
Standards with Optional Coordinated Preventive Control Regulatory Activities and Capacity
Building (U18) Clinical Trial Not Allowed
The Louisiana Department of Agriculture & Forestry’s (LDAF), Office of Animal Health & Food Safety
(AHFS), Feed Program Division is currently finalizing year 5 of the Animal Feed Regulatory Program
Standards (AFRPS) Development and Implementation Grant (RFA-FD-15-021) and expects to be found
in full conformance during the program’s final FDA audit scheduled for August 2020. The LDAF AHFS
Feed Program plans to move forward with the maintenance phase of the FDA AFRPS Program and
enroll in the Preventive Controls (PC) Funding Opportunity to support the FDA Preventive Controls
Initiative. The Feed Program plans to maintain FDA Contract work for feed related activities while
annually increasing the capability and capacity to conduct all comprehensive inspections covered under
21 CFR Part 507. The LDAF AHFS Feed Program will support the LDAF Agricultural Chemistry
Laboratory by providing trained personnel for sample collection allowing the Laboratory to enhance its
scope and capacity. The Feed Program plans to identify and train a qualified field inspection trainer
for comprehensive inspections which include Current Good Manufacturing Practices (cGMP) and
Preventive Controls for Animal Food (PCAF). The program will enhance its outreach program by
identifying outreach venues and developing outreach materials that pertain to PCAF regulation. The
Feed Program plans to move forward with the State Auditor Program by moving towards Phase 2 and 3.
The program plans to participate in and help develop capabilities to share regulatory data with the FDA
through IT interface platforms such as the National Food Safety Data Exchange (NFSDX). The
program will continue to work with the FDA to evaluate an enhance data collection and enforcement
strategies, especially as it pertains to cGMP and PCAF compliance. The Feed Program will continue to
support the FDA by providing current firm inventories categorized by risk. Finally, The LDAF AHFS
Feed Program with develop a sound Exit Strategy by year 5 that will outline how the program will
sustain required resources for program enhancement and implementation, advancements in cGMP/PC
regulatory work activities and maintain full conformance with the AFRPS. Maintaining full
conformance with the AFRPS will assist both Louisiana and the Food and Drug Administration (FDA)
to better direct their regulatory activities toward preventing feed manufacturing compliance issues and
increasing food safety and Public Health within the United States.

Public health relevance
Project Narrative Animal Feed Regulatory Program Standards (AFRPS) Maintenance and the Enhancement of Current Good Manufacturing Practices (cGMP) and Preventive Controls for Animal Food (PCAF) Regulatory Activities Funding under this Cooperative Agreement Grant, “Development and Maintenance of the Animal Feed Regulatory Program Standards with Optional Coordinated Preventive Control Regulatory Activities and Capacity Building (U18) Clinical Trial Not Allowed,” the Louisiana Department of Agriculture & Forestry’s (LDAF), Office of Animal Health & Food Safety, Feed Program Division will be able to maintain full conformance with the Animal Feed Regulatory Program Standards (AFRPS) and support the FDA Preventive Controls Initiative. The overall goal of this project is to develop the capability to maintain conformance to the AFRPS and conduct comprehensive feed inspections covered under 21 CFR Part 507, independent of but in coordination with the FDA. Maintaining full conformance with the AFRPS will assist both Louisiana and the Food and Drug Administration (FDA) to better direct their regulatory activities toward preventing feed manufacturing compliance issues and increasing food safety and Public Health within the United States.